Uncovering Caries Risk in the Noncoding Genome of the Developing Tooth

Project Summary
Caries is a common oral disease that will affect 90% of US adults in the course of their lifetime. Carious lesions
of the tooth develop over time when microbes on the tooth surface respond to carbohydrates by producing acids
that degrade enamel. In addition to lifestyle factors like diet and hygiene, studies have shown a heritable
component of caries risk, which is hypothesized to lie in the enamel proteins made during tooth
development. Genome wide association studies (GWAS) have identified 52 loci containing common variants
associated with caries risk, the majority of which lie in enhancers. Enhancers are noncoding sequences
containing binding motifs that recruit transcription factors and loop to the promoter of a target gene to enhance
its transcription in a time, tissue, and cell type-specific manner to control spatiotemporal gene expression in
development. Enhancer dysfunction can affect expression of target genes in a subset of expression domains in
the body, resulting in tissue-isolated disease, similar to caries presentation. We have observed enrichment of
caries SNPs in enhancers active in craniofacial tissue from Carnegie stages 13-17, which contain the developing
tooth. We observed a similar enrichment of caries SNPs in conserved enhancers of mouse craniofacial regions
from similar developmental stages, including in isolated mouse tooth buds. These results suggest a role for
evolutionarily conserved active enhancers of the early tooth in caries predisposition. While we have associated
specific tooth enhancers with caries risk, their target genes, which may be ultimately responsible for caries
predisposition, remain unidentified. Additionally, these results do not differentiate between the diverse cell types
of the tooth including the enamel knot, dental epithelial cells, and dental mesenchymal cells. Given the production
of enamel matrix proteins by dental epithelial cells during development, we hypothesize that dysregulation of
enamel matrix genes in epithelial cells of the developing tooth, driven by variants in the non-coding
genome, predisposes one to caries development. In this proposal, we will identify cell type-specific
enhancers at evolutionarily conserved loci associated with caries risk and predict their target genes in
the early developing tooth. Aim 1 will identify cell type specific enhancers associated with caries, by
performing scATAC-seq on bud stage mouse incisors and using functional chromatin annotations to identify cell
type-specific enhancers, then applying linkage disequilibrium-based computational methods to find the subset
of enhancers associated with caries risk. Aim 2 will determine caries-associated genes in the dental
epithelium of the early developing tooth by integrating multiple “omics” data sets into an activity by contact
computational model. With this investigation we will identify caries-associated enhancers and their target genes,
which will facilitate quantitative and functional caries risk assays outside the scope of this proposal. The
experiments proposed in this fellowship will provide the opportunity to expand my skills in genomics and single
cell techniques for a career as a clinician-scientist in the field of dental development and disease.

Public health relevance
Narrative Caries is a disease that affects 90% of US adults in their lifetime, which poses a significant public health burden. While it is known that caries is linked to oral hygiene, diet, and the oral microbiome, it has been shown to have a genetic component that has largely remained unstudied. The work outlined in this proposal will provide insight into the connection between early dental development and predisposition to caries development.